Memory Regulatory T cells in Recurring Malaria

PROJECT SUMMARY
Regulatory T cells or ‘Tregs’ play a critical role in our health and well-being by suppressing over-
exuberant immune responses. Antigen-specific Tregs, like other T cell subsets, are maintained
for prolonged periods in the host as memory Tregs (mTregs). These are possibly recalled to
protect against the immunopathology associated with repeated encounters with the same antigen.
Initial observations supporting this notion in viral infection models have generated immense
interest, especially from the fields of autoimmune diseases, allergy medicine, maternal-fetal
medicine, or recurrent infectious diseases, where repeated exposures to self or non-self antigens
are fundamental. Malaria, caused by Plasmodium, is one such disease, where humans residing
in endemic areas get repeatedly infected. However, Tregs are known to impede the protective
immune responses against Plasmodium during a primary infection. Therefore, we expected the
mTregs also to behave similarly by hindering protection in both humans and mice following
Plasmodium re-exposure. Surprisingly, humans possessing higher frequencies of mTregs
exhibited reduced parasite loads upon reinfection. In mice also, the presence of mTregs promoted
better control of repeat infections with Plasmodium. These findings suggested that Tregs behave
differently in primary and secondary infections during malaria and challenged the fundamental
concept of functional memory in T cells. The primary objective of this research proposal is to
determine the mechanisms underlying mTregs-mediated protection and function in recurrent
malaria. Our preliminary experiments suggest that the mTregs generated by Plasmodium
infection transition to Tfh-like cells that promote anti-Plasmodium immunity. Our central
hypothesis is that mTregs undergo inflammation-induced epigenetic modifications to enable their
pheno-conversion into Tfh-like cells during recall and promote the generation of robust germinal
center (GC) reaction and antibody responses. This would facilitate better control of Plasmodium
reinfection. We will test this hypothesis by determining the molecular mechanism of the transition
of mTregs to Tfh-like cells (Specific Aim1) and resolving how such a transition would promote
immunity to Plasmodium reinfection (Specific Aim 2). We think that the mTregs maintained in
malaria-experienced individuals are a transitionary state of Tfh cells, allowing such cells to survive
for prolonged periods in the host. The completion of our proposed studies would provide new
insights into how mTregs can impact disease outcomes in recurrent infections such as malaria,
where reinfections constitute the majority of the clinical cases in humans.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because, understanding why and how immune cells that are considered immunosuppressive in nature enhance protection in individuals repeatedly infected with malaria would lead to significant changes in our approaches to treating clinical malaria in older children and adults living in or returning to malaria-endemic areas. The proposed research is therefore relevant to the core mission of the NIH pertaining to acquisition of fundamental knowledge about the nature and behavior of living systems, and the application of that knowledge to enhance health, and reduce the burdens of illness in our society.